Evaluating the Impact of Supplementing Residential Substance Use Treatment with Written Exposure Therapy for Veterans with Co-Occurring PTSD and Substance Use Disorders

Posttraumatic Stress Disorder (PTSD) and Substance Use Disorder (SUD) are highly comorbid, and
comorbidity increases risk for poor functional outcomes. SUDs are associated with poor functional outcomes
such as quality of life, community engagement, and suicide (Teeters, Lancaster, Brown & Back, 2017). Risks
for poor quality of life and suicide increase further for those with co-occurring PTSD and SUD diagnoses as
compared to either condition alone, with suicide attempt rates three times higher for Veterans with alcohol use
disorder and PTSD (Norman, Haller, Hamblen, Southwick & Pietrzak, 2018). For patients with PTSD-SUD,
there is evidence of greater PTSD symptom severity and poorer SUD treatment outcomes (e.g., Back et al.,
2000), as well as higher rates of homelessness and disability (Bowe & Rosenheck, 2015). PTSD-SUD
treatments have shown promising reductions in PTSD and SUD symptoms (Flanagan, Korte, Killeen & Back,
2016). Yet, there are still major challenges in widely implementing concurrent or single-target gold-standard
treatments for this population, especially with rural veterans where care access may be limited (e.g., Flanagan
et al., 2016). Written Exposure Therapy (WET) is a front-line, brief and effective treatment for PTSD that
addresses some of the challenges posed by other gold-standard treatments. This project is designed to
examine the feasibility and acceptability of Written Exposure Therapy (WET) delivered to Veterans with
comorbid PTSD-SUD while they are completing a 28 day-residential SUD program (DOM SUD). The
preliminary effects of the treatment during the program, and at one month and 3 month follow-up periods will
also be examined, with particular attention to rates of substance use, homelessness, treatment attendance,
treatment completion, quality of life, suicidality, and PTSD and depression symptoms. Veterans enrolled in the
DOM SUD with PTSD Checklist-5 (PCL-5) scores over 33 will be recruited for further screening into the study.
Those that meet criteria for PTSD through confirmation using the Clinician Administered PTSD Scale for DSM-
5 (CAPS-5) will be randomized into one of two treatment arms: Treatment as Usual (DOM SUD) and Written
Exposure Therapy in a residential SUD program (resWET). Randomization will be stratified by gender and
oversampling for women and minority participants will be used. Those in the TAU control group will participate
in the DOM SUD treatment program, while those in the resWET group will also have five individual treatment
sessions of WET. Participants will complete weekly measures of symptoms, in addition to rating cravings for
substance use. Treatment completion rates will also be compiled for both DOM SUD and resWET. Participants
will complete pre-treatment, post-treatment, 1 month, and 3 month follow-up measures in person, over video,
or by phone, and these measures, along with data available from the treatment record, will be examined using
descriptive analyses to look for important trends regarding both symptom responses (e.g., PTSD, depression)
to treatment, as well as behavioral and functional outcomes (such as suicide attempts, homelessness,
treatment attendance, treatment completion, substance use, disability). This preliminary data will be used to
inform future studies using this treatment approach. Additionally, providers in the DOM SUD will complete
treatment feasibility and acceptability measures and focus groups to provide essential information about
implementation barriers that need to be addressed for the uptake of the treatment approach and to enhance
the accessibility of the treatment. All Veterans will also provide feedback about their treatment, through survey
when the treatment is complete, and focus group participation. Findings from both qualitative and quantitative
data will be used to improve the treatment and assessment approach and to determine effect sizes of key
measures (WHO-DAS, PCL, PHQ-9) to prepare for a fully powered RCT to systematically evaluate resWET.

Public health relevance
The implications and impact of this research on Veterans’ health and our healthcare delivery and standard treatment approach is substantial. Untreated PTSD has significant costs for the individual, family, and community, as well as financial and medical costs for the VA. This research moves us toward more equitable and efficient care models that are also effective and greatly enhance treatment access. We propose that effective treatment should greatly enhance quality of life measures and community functioning, while reducing morbidity and suicide rates, substance use, homelessness, PTSD, and depression symptoms. The knowledge gained from this study will provide valuable insights into the functional domains influenced by PTSD-SUD treatment and highlight implementation benefits and challenges so improvements can be made to the assessment and treatment approach. In addition, by examining and addressing any provider, patient, and clinic barriers to implementation, this research can greatly improve the likelihood of successful and wide implementation of a new concurrent treatment approach across residential substance use disorder programs.